Convergent cellular and network mechanisms of ASD risk genes

ABSTRACT
A decade of gene discovery identified over 250 genes highly associated to autism spectrum disorder (ASD). One
of the next critical steps to better understand ASD etiology is to determine how ASD risk genes converge on
cellular and network function. One central locus at which ASD risk genes converge are prefrontal cortex (PFC)
layer 5 pyramidal neurons. Layer 5 pyramidal neurons have specialized dendritic arbors thought to function as
coincidence detectors to effectively integrate both local and long-range synaptic inputs. Abnormal dendritic
processing is suggested to contribute to social, cognitive, and communication deficits typically observed in ASD.
Our lab has recently identified dendritic impairments in mice haploinsufficient for Scn2a, which has some of the
strongest associated scores to ASD. Here, I will test the central hypothesis that multiple ASD risk genes with
distinct biological functions converge on impairments in dendritic excitability and synaptic integration. This work
is expected to reveal whether dendritic excitability is indeed a point of convergence across high-risk ASD genes
and will uncover precisely which aspects of dendritic excitability are most affected in these cases. In addition,
most ASD risk genes are known or predicted to cause ASD due to haploinsufficiency. I will also test whether cis-
regulation gene therapy could be a viable therapeutic approach to restore ASD risk gene haploinsufficiency and
downstream deficits in dendritic and synaptic functions. Our results will have a positive impact as this work will
reveal mechanisms that contribute to altered dendritic excitability, which, in turn, may give us greater insight to
the pathophysiology of ASD and may provide a novel therapeutic approach to restore convergent features of
neuronal and network dysfunction.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) is a life-long neurodevelopmental disorder of which there are currently no effective treatments for due to a limited understanding of the underlying pathophysiology. This work focuses on understanding how ASD risk genes converge in the dendrites of pyramidal neurons in the prefrontal cortex, a brain region implicated in ASD etiology. This project will shed light on the cellular processes that contribute to ASD and may reveal new therapeutic strategies to rescue cellular and network functions.